The Drugged Driving Resources Website for the prevention of drugged driving

DESCRIPTION (provided by applicant): The overall objective of the proposed project is to complete the development of and evaluate the Drugged Driving Resources website (www.druggeddrivingresources.com). Drugged driving is a significant public health and safety concern and there is an increasing need for information resources on the topic of drugged driving to help guide prevention efforts. The Drugged Driving Resources website will include free resources and products to assist a diverse group of stakeholders in locating research, selecting prevention and treatment programs, reviewing laws and policies, collecting data, and receiving training on the topic of drugged driving. There are four main resources hosted on the Drugged Driving Resources (DDR) website; the Drugged Driving Research Library, Drugged Driving Intervention Library, Drugged Driving Data Collection System, and the Drugged Driving Resources Training. The first year of the project will focus on revision to the four resources that compose the website as well as expansion of these resources to include new content and additional functionality. In addition, a small one-to-one usability study will be conducted. The second year of the project will involve conducting a randomized controlled trial to evaluate the effectiveness of the website for increasing user's knowledge about drugged driving and subsequent implementation of drugged driving prevention activities. The completion of these web-based resources and products will result in increased implementation of drugged driving prevention efforts, increased public awareness of drugged driving, improvements in the collection of standardized data on the topic of drugged driving, easier access to data sources related to drugged driving, better knowledge of the laws and policies related to drugged driving, easier selection of evidence-based prevention and treatment programs, and high-quality drugged driving training.

Public health relevance
PUBLIC HEALTH RELEVANCE: Drugged driving is a significant public health and safety concern and there is an increasing need for information resources on the topic of drugged driving to help guide prevention efforts. The purpose of this Phase II project is to complete the development of the Drugged Driving Resources website and evaluate the effectiveness of the Drugged Driving Resources website for increasing user's knowledge and intentions to engage in drugged driving prevention activities. This project will result in the development of a commercially available, rigorously- tested website of resources with the goal of increasing knowledge and awareness of drugged driving and increasing drugged driving prevention efforts in communities across the country.